Western States Node of the National Drug Abuse Treatment Clinical Trials Network

Project Summary
The Western States Node (WSN), a partnership between Oregon Health & Science University (OHSU),
Stanford University/Palo Alto VA, University of California San Francisco (UCSF) and the San Francisco
Department of Public Health, tests interventions to fill gaps in the addiction care cascade. Progressively fewer
people who use drugs (PWUD) remain in care after each step in the cascade, resulting in unacceptably high
morbidity and mortality. In concept and practice. Six diverse systems partner with the WSN to develop
innovative CTN research: 1) Palo Alto VA and the national Veterans Healthcare Administration; 2) OHSU
Health, 3) Stanford Hospital and Clinics, 4) Four community-based Opioid Treatment Programs serving rural
and urban communities, 5) Low-barrier telehealth SUD programs, and 6) The PRIME+ network of 14
community-based peer organizations that provide outreach and harm reduction services to non-treatment-
seeking PWUD in rural and urban communities.
The WSN’s competing renewal application proposes collaborative research within the CTN that fills gaps in
the addiction care cascade and enhances the lives of PWUD and their families and communities. Our
addiction care cascade-focused research agenda was developed in conversations with our diverse team --
investigators, care providers, policy makers, and the WSN Community Council of PWUD and people in
recovery. The Community Council prioritized the need to test new medications and behavioral treatments to
initiate and retain people using fentanyl in care and to integrate peer support services into treatment and
research settings, leading to two research agenda themes. Research Theme 1 seeks to close addiction care
cascade gaps through treatment trials. An exemplar trial tests slow-release oral morphine induction versus
standard buprenorphine inductions in 350 people who use fentanyl to improve buprenorphine treatment
engagement and retention. Research Theme 2 seeks to integrate community-based peers into CTN trials that
extend beyond traditional addiction treatment systems. WSN tests novel peer interventions to improve
community-based outreach, treatment engagement and retention for diverse populations. WSN’s peer
organization network amplifies the voices of peers in CTN research and brings an equity lens to expanding
buprenorphine access and retention in rural and other under-served populations. WSN offers these resources
to the CTN network for use in future CTN protocols. WSN continues to use the CTN as a platform for training,
dissemination, and research applications. Our proposal seeks to reclaim approximately 225,000 years of
healthy life lost each year to drug use in the U.S., and address NIDA’s Strategic Plan priorities to: a) develop
and test novel treatment, harm reduction, and recovery support strategies, and b) study the implementation of
evidence-based strategies in real-world settings.

Public health relevance
Project Narrative The Western States Node is a collaboration across leading universities and health care organizations which develops and tests strategies that close gaps in the addiction treatment cascade. An exemplar trial tests slow-release oral morphine induction versus standard buprenorphine induction in 350 people who use fentanyl, to improve treatment engagement and retention. The trial, like the Node as a whole, also incorporates peers (individuals with lived experience in recovery) as advisors, research assistants, and supporters of high-quality care.